Comprehensive and Cell Type-Specific Proteogenomic Profiling of Aberrant and Mis-Processed Proteins in Alzheimer's Disease and Tauopathy Models

Project Summary
In Alzheimer's disease (AD), the most common form of dementia, aberrant and mis-processed proteins
accumulate throughout the brain. AD-associated aberrant and mis-processed proteins may result from a variety
of mechanisms, including protein-altering DNA sequence differences, dysregulated mRNA splicing, post-
translational modiﬁcations, proteolytic cleavages, and protein misfolding. Although these mechanisms are
known to affect a handful of proteins in AD, we have not been able to comprehensively characterize their impact
on the proteome because of technological and methodological limitations. Thus, new approaches that can
systematically proﬁle aberrant and mis-processed proteins in AD are needed to improve our understanding of
the disease's causes and identify actionable therapeutic targets. AD-associated protein dysfunctions also
differentially affect distinct brain regions and cell types. To understand the factors responsible for this
heterogeneity, we need approaches with sufﬁcient scale to proﬁle multiple brain regions and sufﬁcient resolution
to proﬁle individual cells. Here, we pair state-of-the-art proteomic methods that we developed with
proteogenomics, an approach that integrates genomic, transcriptomic, and proteomic data. The resulting
proteogenomic pipeline will allow us to globally proﬁle disease-associated proteins with amino acid substitutions,
alternative protein isoforms, post-translationally modiﬁed proteins, and proteolytic cleavage products. In Aim 1,
we apply our proteogenomic pipeline to multiple brain regions in a large AD cohort and multiple tauopathy mouse
models. By proﬁling brain regions selectively vulnerable versus resilient to neurodegeneration in AD, the full
spectrum of AD pathological stages, multiple disease subtypes, and multiple tauopathy mouse models using
mass spectrometry methods that provide high proteome and individual protein sequence coverage, we will
substantially expand our understanding of protein dysfunctions in AD. In Aim 2, we pair proteogenomics with
the pioneering single-cell mass spectrometric proteomic methods we developed. We will proﬁle individual
neurons and non-neuronal cells extracted from human AD and tauopathy mouse brain tissues to provide needed
insights into the cell type-speciﬁc factors that cause protein dysfunctions in AD. Across both aims, we apply
rigorous experimental methods for functional validation and analytical approaches for causal inference to
mechanistically characterize AD-associated aberrant and mis-processed proteins. Collectively, our aims will
improve our understanding of AD's causes, identify new AD therapeutic targets, and provide new tools for
studying protein dysfunctions in AD.

Public health relevance
Project Narrative In Alzheimer's disease (AD), abnormal proteins that contribute to disease onset and progression accumulate throughout the brain. Abnormal proteins may accumulate in AD through a diverse array of genetic, biochemical, and molecular mechanisms and, owing to this complexity, we have a limited understanding of which abnormal proteins accumulate, their role in disease, and how to target them therapeutically. We propose new approaches for comprehensively identifying and validating abnormal proteins in multiple brain regions and single cells from AD patients, which will improve our understanding of AD's causes and identify novel AD therapeutic targets.